Imaging, image guided biopsy and treatment of prostate cancer

The project titled "Imaging, Image-Guided Biopsy, and Treatment of Prostate Cancer" focuses on the development and clinical translation of advanced imaging technologies-including high-resolution Magnetic Resonance Imaging (MRI), molecular imaging, and artificial intelligence (AI)-driven image analysis-to improve the detection, characterization, and management of prostate cancer. MRI protocols have been refined to offer higher spatial and temporal resolution, improving lesion detection and anatomical detail. AI models have been further integrated into clinical workflows to enable automated, objective evaluation of prostate MRI, reducing inter-reader variability and improving efficiency. We performed AI assisted prostate biopsies for >200 patients in the last year. The TULSA (Transurethral Ultrasound Ablation) system has been employed for MRI-guided focal therapy, offering a minimally invasive option for ablating targeted cancerous tissue. We have completed the patient accrual for our TULSA protocol. We developed a novel approach, "AI-ADC", which allows us to produce ADC maps from T2W MRI. This technique has been documented to provide better quality ADC maps compared to acquired ADC maps. Additionally, we launched a new protocol which includes use of cancer prediction maps derived from hybrid-MRI. Finally, we build AI systems to control quality of prostate MRIs.